Carbon Nanotube-Mediated Gene Transfer into Human T-cells for CAR-T HIV Therapy

ABSTRACT
The HIV pandemic has caused an estimated 33 million deaths to date. In the U.S. alone, 1.2 million people
currently live with HIV and 34,800 new cases were diagnosed in 2019. This adds up to an estimated $16.4 billion
for a lifetime of HIV treatment for patients in the U.S. HIV infects immune cells which express the CD4 and
CXCR4/CCR5 co-receptors including helper T-cells. Even after a patient mounts an initial, effective immune
response, the virus persists undetected by the immune system in quiescently infected CD4+ T-cells. For this
reason, the primary treatment for HIV, combined antiretroviral therapy (cART), is not able to eradicate HIV from
patients. Many HIV patients are able to live with continuous treatment, but this is both costly and uncertain to
remain effective given the recent identification of a more virulent strain of HIV-1 in which patients suffer an
accelerated loss of CD4+ T-cells. There is a critical need for innovative, efficacious therapeutics to direct a more
robust immune attack of the virus.
One promising strategy is to generate more active anti-HIV CD8+ cells. Chimeric Antigen Receptor-T cell (CAR-
T) is a relatively new process in which patient T-cells can be programmed to attack cells expressing a target
protein characteristic of a specific disease. When used with agents to make infected cells visible, it has been
hypothesized that CAR-T will support the host immune system to fully eradicate HIV-infected cells. There are
currently several technological limitations to the production of CAR-T cells, and the rate limiting step is transfer
of genetic material into the primary T-cells to program them to eliminate cells expressing a target protein. Current
methods of creating CAR-T cells demonstrate an inefficiency barring translation from the laboratory to clinical
settings. Lipofection inefficiently transfects primary T-cells, and electroporation and biolistics both damage cells.
Retroviruses are limited to 8-10 kb of genetic material which limits advanced applications, are toxic to cells if
used at too high a dose, and are complex to construct. In addition, retroviruses integrate into their target cell’s
genome which could inactivate a tumor suppressor gene and create tumors.
AGTC has developed a novel method of introducing biomolecules into mammalian cells using an array of closely
packed, aligned carbon nanotubes to achieve highly efficient transfer with low cytotoxicity and high capacity for
genetic cargo. This technology has potential to overcome size limits of current gene-transfer technologies in
addition to being simpler, faster, and more flexible. In this proposal, AGTC will (1) optimize gene transfer into
primary human T-cells using carbon nanotube technology (CNT); and (2) create human anti-HIV CD8+ CAR-T
cells against HIV envelope glycoprotein, gp120. Successful completion of the proposed work will enhance
knowledge about CNT capabilities, and allow AGTC to proceed to further testing of the CAR-T cell product with
an eye to therapeutic use in HIV positive patients.

Public health relevance
NARRATIVE About 1.2 million people in the U.S. live with HIV which generates a health care burden of about $16.4 billion for a lifetime of treatment. The primary treatment for HIV is combined antiretroviral therapy (cART); however, despite being able to slow or stop HIV infection, cART is not able to completely eradicate HIV from patients. The current proposal will create Chimeric Antigen Receptor-T cells (CAR-T), a relatively new method to enhance the immune response, using our proprietary carbon nanotube technology (CNT) to target and eliminate HIV infected cells.